UC Davis Clinical and Translational Science Center

PROJECT SUMMARY/ABSTRACT
The Clinical and Translational Science Center (CTSC) at UC Davis serves as a catalyst to support biomedical
research through services and resources to investigators, staff, scholars, trainees, and community partners.
The CTSC partners with all UC Davis schools and colleges engaged in life science and translational research
to support collaborative projects with the potential to improve health care. It provides a centralized resource
dedicated to facilitating biomedical research through innovation, collaboration, and expertise. Specifically, the
CTSC: 1. serves as a hub for clinical and translational research resources, which will serve as an invaluable
resource for the success of this grant. (2) expands and refines a collaborative and innovative training and
education environment, (3) integrates community partners into the translational research enterprise, (4)
leverages crosscutting research resources, and (5) functions as a catalyst across the translational research
spectrum. The focus of the CTSC informatics, bioethics and community engagement resources of the CTSC
are to advance the efficient, scalable and ethical design and implementation of clinical research resources and
data and collaborate with other CTSA hubs to leverage and share methods, practices and guidelines in this
domain.
The Research Data Ethics Maturity Model (README) project will seek build on the CTSCs commitment to
training the next generation of translational data scientists, and identify the maturity of ethical frameworks used
within translational data-science generating projects, capture gaps and classifications from project,
stakeholder, tool and impact perspectives, and partner with new research development to provide enhanced
use of ethical frameworks and resources throughout development data lifecycles. The project will generate a
data ethics maturity framework for generalization to other environments, and new training and resources
surrounding each stage of data science design, curation, modeling, and application.

Public health relevance
PROJECT NARRATIVE The Research Data Ethics Maturity Model (README) project will seek identify the levels of maturity of ethical frameworks and resources within the development of translational data-science generating projects, capture gaps and classifications from project, stakeholder, tool and impact perspectives, and partner with new research development to provide enhanced use of ethical frameworks and resources throughout development data lifecycles. The project will generate a data ethics maturity framework for generalization to other environments, and new training and resources surrounding each stage of data science design, curation, modeling, and application.